2025 CAG Triplet Repeat Disorders Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY/ABSTRACT
The goals of this conference are the following: 1) to enhance the exchange of information related to CAG
expansion diseases. This is one of the few opportunities where scientists from a broad range of disciplines can
attend a conference on all the CAG repeat disorders. They will hear about advances in other repeat disorders
that illuminate common mechanisms and unravel the ones relevant to each of these diseases; 2) to stimulate
global collaborative research to advance our understanding of human CAG triplet repeat diseases. The Gordon
Research Conference on CAG Triplet Repeat Disorders has an outstanding record of fostering successful
exchange and collaboration and has encouraged breakthrough research; 3) to provide junior investigators with
an opportunity to present their latest work and interact with leading scientists, and to promote diversity among
investigators of CAG triplet diseases. We will attract the best young minds in the field with a comprehensive and
intellectually stimulating program. They will have ample opportunities to present their concepts and results in
both poster and oral presentation formats, and the opportunity to receive mentorship and support in developing
their research career. 4) to increase our understanding of the function and dysfunction of the disease-causing
DNA, RNA, and proteins to advance the development of disease-modifying therapeutics. We are committed to
developing a diverse program and inclusive atmosphere at the conference. We have already succeeded in
having 50% of confirmed speakers and discussion leaders thus far who are women, and three confirmed/invited
speakers/discussion leaders are from Asia. As we continue to invite speakers, we will ensure that >50% are
women and that >5% are of minority racial and ethnic backgrounds since >50% of the talks will be chosen from
abstracts. A Power Hour will be organized, which is an hour-long informal gathering to address diversity and
inclusion in the scientific workplace by providing a safe environment for informal and meaningful conversations
amongst colleagues of all career stages, supporting the professional growth of all members of our communities.
Overall, the conference will provide a unique opportunity to gather a wide range of diverse scientists at all career
stages from the global community to share and discuss the latest developments in CAG Triplet Repeat Disorders
in an inclusive and stimulating environment.

Public health relevance
PROJECT NARRATIVE The 2025 Gordon Research Conference on CAG Triplet Repeat Disorders will gather leading scientists from around the world to discuss novel high-impact research on CAG Triplet Repeat Disorders. We are developing an exciting scientific program, as described in the application, that emphasizes commonalities and differences in the pathogenic mechanisms of the CAG repeat disorders and discusses novel state-of-the-art approaches to study the functions and dysfunctions of the proteins mutated in this family of disorders with the objective of identifying new potentially disease-modifying therapeutic approaches.